Administrative Core

PROJECT SUMMARY (Administrative Core)
The Administrative Core provides essential support to the MD Anderson Cancer Center Prostate Cancer
SPORE (Prostate Cancer SPORE) PIs and investigators to maximize success. It is directed by Drs.
Christopher J. Logothetis and Timothy C. Thompson and co-directed by Dr. Sue-Hwa Lin, who co-chair the
Executive Committee and provide overall supervision of 4 Projects, 2 additional Cores, Developmental
Research (DRP) and Career Enhancement (CEP) Programs, and scientific direction of the SPORE. The Core
Directors and co-Director rely on the extensive broad-based scientific, research, and SPORE experience of
the Advisory Boards in critical decision-making. Success of the complex interdisciplinary research in the
SPORE depends in part on integration of diverse prostate cancer research approaches. The Core will
overcome barriers to interdisciplinary collaboration and data sharing and ensure a unified translational
research effort. The SPORE is founded on planning, integration, and translational research efforts supported
by this Core. Its leadership and staff will be responsible for monitoring/planning scientific activities; providing
scientific direction; ensuring emphasis on translational research; ensuring interdisciplinary and inter-SPORE
integration with major prostate programs within/outside MD Anderson and other broad translational research
activities; and providing administrative and fiscal management (eg, personnel, budgets, office oversight,
communication, organization of meetings, manuscript preparation, and progress and other reports to the NCI
and SPORE committees, and support of Cores and Programs). Specific responsibilities of the Administrative
Core are to: monitor research activity and provide stable and continuous leadership and direction; promote
integration, communication, and collaboration among the SPORE and collaborating investigators at MD
Anderson and other Texas Medical Center institutions; monitor scientific integrity and ensure overall
compliance with all institutional, state, federal, and NCI regulations and requirements, as well as assurance for
data quality control for the Biostatistics and Bioinformatics and Biospecimen and Pathology Cores; provide
oversight for completion of DRP and CEP goals; convene, staff, and manage all necessary meetings; oversee
expenditures and maintain budgets; communicate and consult with the NCI Translational Research Program
Director and staff, including reports; increase awareness of prostate cancer research and patient advocacy in
the community; address ongoing needs of minority and underserved communities in Houston and Harris
County (Texas); and encourage and facilitate translational prostate cancer research by extramural groups
within the region and throughout the US.

Public health relevance
PROJECT NARRATIVE (Administrative Core) The principal role of the Administrative Core of the MD Anderson Cancer Center Prostate Cancer SPORE is to expand the integration of investigators from diverse scientific disciplines who have joined the translational research effort in prostate cancer, and to provide continuous leadership and general administrative support for all SPORE-related activities.